Administrative Supplement - 3/3: Community Psychology Risk Screening: An Instrument Development Study

Project Summary/Abstract
The proposed study aims to develop a brief, valid screening questionnaire to identify individuals at risk for
psychosis in non-clinical populations across 3 large, community catchment areas with diverse populations.
This is a needed study, as the current screening tools for at-risk psychotic populations have been validated
only in clinical and/or treatment seeking samples, which are not likely to generalize beyond these specialized
settings. The proposed project will administer 3 well-known psychosis risk screeners, as well as symptom-
based (e.g., depression, anxiety, etc.) and risk-factor based questionnaires (e.g., cannabis and other
substance use, a family history of major mental disorders, trauma history) to 12,000 adolescents/young adults
in local communities across 3 demographically diverse sites (the greater Philadelphia, Baltimore, and Chicago
areas, including neighboring rural/suburban areas). Based on established cut-off scores from the 3 psychosis
screeners, 2,000 subjects deemed as questionnaire higher risk (QHR; n=1,000) and questionnaire lower risk
(QLR; n=1,000) for psychosis (estimated sample sizes based on pilot data and anticipated loss to follow up)
will be invited to complete semi-structured interviews to determine clinical high risk (CHR) for psychosis status
based on the Structured Interview for Psychosis-Risk Syndromes (SIPS) and to assess current/past major
mental disorders based on the Structured Clinical Interview for DSM-5 (SCID-5). The SIPS psychosis-risk
persistence syndromes and the DSM-5 attenuated positive syndrome (both assessed with the SIPS 5.6) also
will be collected and will be examined in supplementary analyses. Based on preliminary data and conservative
estimates, we anticipate that 186 of the QHR group will be considered CHR for psychosis. The specific aims
are as follows: 1) to determine norms and prevalence rates of attenuated positive psychotic symptoms across
3 diverse, community catchment areas and 2) to develop a screening questionnaire, inclusive of both
symptom-based and risk factor-based questions, that is validated against the SIPS to identify those at CHR for
psychosis in the community. This is the first study in the U.S. to determine the rate of subthreshold psychotic
symptoms across diverse non-help seeking samples, which is essential for any investigation that uses
dimensional approaches to psychotic disorders. Further, the proposed study will develop an essential
screening tool that will identify which individuals have the greatest need of follow-up with structured interviews
in CHR studies or clinical settings to determine psychosis-risk status. This tool is will be valuable given findings
that those who develop psychotic disorders often do not seek treatment until after the onset of the disorder,
and that duration of untreated psychosis is associated with more serious clinical outcomes. The proposed
study has the potential for major contributions to the early detection and prevention of psychotic disorders. The
supplement would help realize the full import of this project following the unprecedented COVID-19 pandemic.

Public health relevance
Project Narrative: To date, all screening tools to detect individuals at risk for psychosis have been designed for individuals who are help-seeking and/or exhibiting signs of psychosis. Given the impact of the pandemic on data collection, this supplement will be invaluable with continuation of the project. The proposed multi-site project aims to develop a valid psychosis-risk screening tool using non-clinical samples across 3 large, diverse, US catchment areas.